Airborne delivery of microbots for chemical and mechanical attack of pulmonary biofilms

Project Summary: In cystic fibrosis (CF), treatment is difficult because chronic lung infections lead to biofilm formation and drug-resistant bacterial strains prevent antibiotics from working effectively. Antibiotic approaches specifically designed to address infections in the lung include inhaled antibiotics; however, resistant strains are a significant challenge. For delivery, such inhaled drugs must be formulated within a specified size range. Too large and they do not remain suspended to reach deep within the lungs. Too small and they remain in the air and are simply exhaled without embedding. Our scientific premise is that individual magnetic particles of this optimal size range can be inhaled into the lungs and subsequently assembled in place in the form of wheel-like assemblies, or µwheels, to travel deep down lung pathways and disrupt mucus layers to enhance drug-induced biofilm removal. As both µwheel assembly and driving forces are provided by an external magnetic field, once the procedure is finished, devices “self- disassemble” into small building blocks removable by the body's natural mechanism for removal of dust and other foreign particles in the mucus lining. Our aims include: Aim 1: Identify applied magnetic field conditions that promote µwheel-enhanced biofilm degradation. We will study model P. aeruginosa and CF patient-derived biofilms, with and without artificial sputum, and attach antibiotics or dispersal agents onto the magnetic particle surface and within tortuous microenvironments. We will also use nanoparticle-decorated µwheels to perforate and penetrate the film and test with antibiotic/dispersal agent in solution. Aim 2: Determine conditions that support airborne delivery and transport of µwheels in 3D environments. We will demonstrate airborne delivery of µwheels and translation within 3D models of patient respiratory systems, with and without artificial sputum.

Public health relevance
Project Narrative: We propose a method for treatment of pulmonary diseases based on aerosolized magnetic particles that assemble into functional microbots that travel deep into the respiratory system. Focused here on the treatment of cystic fibrosis, our approach combines mechanical and pharmacological methods to break through and dissolve mucus to better deliver antibiotic and related treatments.